Assessment of Alcoholic Hepatitis with Multiparametric Magnetic Resonance Elastography

PROJECT SUMMARY/ABSTRACT
Alcoholic hepatitis (AH) is a major cause of morbidity and mortality due to a lack of effective treatments. There
is an unmet need for reliable noninvasive diagnosis, prognosis, and disease monitoring surrogate markers in
AH patients, who often have challenging clinical diagnoses and high risks of complications with invasive liver
biopsy. The overall goals of this proposal are to perform both preclinical (phase UH2) and clinical (phase UH3)
studies to evaluate multiple magnetic resonance elastography (MRE) biomarkers to assess AH disease
severity and monitor treatment responses. Our central hypothesis is that a multiparametric liver MRE, called a
hepatogram, can provide accurate parameters for assessing AH disease progression and regression, including
changes in steatosis, inflammation, and fibrosis. We believe that AH disease severity and treatment responses
can be quantified when the hepatogram is integrated into a composite metric that can serve as a “virtual
biopsy,” providing a reliable noninvasive surrogate for assessing AH disease severity. In phase UH2 (years 1-2;
Aim 1), we will advance MRE technology to validate the relationships between each imaging parameter and
the corresponding histologic feature in mice administered ethanol (EtOH). A statistical model will expand the
use of these imaging biomarkers to an all-in-one diagnostic or prognostic score for AH. Recombinant IL-22, an
agent that ameliorates hepatic steatosis and inflammation in mouse models will be used to promote disease
regression. We will test the ability of MRE in a longitudinal study for assessing AH severity and evaluate
changes of each parameter for indicating both disease progression and regression in AH mouse models with
placebo or IL-22 treatment. In phase UH3 (years 3-5; Aim 2), we will verify MRE reliability for assessing AH
disease severity and treatment responses in patients with AH. Predicated on the upcoming translational
patient-oriented studies (RFA AA-18-002 and RFA AA-18-005) in the AlcHepNet at Mayo Clinic, we will
perform a baseline MRE in patients who have had liver biopsies as part of their clinical care. We will verify the
reliability of each imaging surrogate from MRE for correlation with histology features (steatosis, inflammation,
and fibrosis). Additionally, a statistical model of this all-in-one “virtual biopsy” will be verified. We will also
perform baseline, 30-, and 90-day follow-up hepatograms in the placebo and IL-22 cohorts from patients
enrolled in a Mayo treatment trial of IL-22 (in response to RFA AA-18-005). This will allow us to evaluate MRE
parameter changes in AH progression and regression respectively by correlating changes in MRE with
changes in Model of End Stage Liver Disease (MELD) scores. In summary, successful verification of this novel
MRE based biomarker in the proposed preclinical and clinical studies would have tremendous applications for
assessing AH disease severity and response to therapy.

Public health relevance
PROJECT NARRATIVE This research will develop and explore hepatic magnetic resonance imaging in patients with alcoholic hepatitis. The success of this proposed study will advance our understanding and ability to diagnose and monitor this disease.